Cargo-responsive mechanisms in autophagy

Project Summary/Abstract
The removal of toxic or unwanted cellular structures – such as protein aggregates, intracellular pathogens
and damaged organelles – presents a fundamental challenge for eukaryotic cells. To eliminate these structures,
which are too large and too complex for the proteasome, cells require an alternative degradation pathway,
autophagy. The predominant view in the field is that all autophagy targets are degraded by a common
mechanism. However, this understanding comes primarily from studies of only a few model substrates, with the
unsubstantiated assumption that other cargoes behave similarly. To test this model, I developed a panel of
cargo-specific autophagy reporters amenable to genetic screening, quantitative microscopy, and biochemical
manipulation. By this approach, I discovered that autophagy cargo (and their receptors) are instructive for
autophagy, such that different cargoes can induce autophagy via different mechanisms. In the process, I
discovered a new cohort of proteins that facilitate cargo selection and autophagosome initiation. Going forward,
the broad goal of our work is to apply our receptor-centric paradigm to reveal new autophagy mechanisms,
dissect the physiological impact(s) of autophagy, and elucidate heretofore unknown lysosomal trafficking
pathways. We expect our studies to reshape the traditional view of how autophagy factors function into a more
complex web of overlapping mechanisms that ensure robust cytoplasm-to-lysosome delivery. In doing so, we
will reveal conserved principles of autophagy and inform our understanding of autophagy dysregulation in
disease.

Public health relevance
Project Narrative The dysregulation of autophagy is associated with cancer, neurodegeneration and aging, but the mechanistic details behind these relationships are poorly understood. The proposed research will elucidate the role of autophagy receptors in selective autophagy, focusing on the mechanism(s) by which receptors identify potentially toxic structures and induce their degradation. A thorough understanding of autophagy induction mechanisms will inform our understanding of how autophagy becomes dysregulated in disease and guide therapeutic attempts to ameliorate these deficiencies.